Statistical and high-throughput models of enhancer function and evolution

Project Summary
This diversity supplement proposes to train Mr. Christian Burns, an African American
master’s student, in modern methods of comparative genomics and genome biology.
African Americans are severely underrepresented in evolutionary biology and this
supplement will assist Mr. Burns in reaching his goal of gaining admission to a top PhD
program and furthering his career towards becoming a faculty at an R1 university. Our
main Aim is to train Mr. Burns in basic skills in genome biology, including long-read
genome sequencing, assembly, annotation and comparative analysis. This training will
be accomplished through a research project building on recent work in the PI laboratory
that revealed dramatic differences in transposable element (TE) abundance in two closely
related, cryptic species of thrushes (family Turdidae). Catharus bicknelli and C. minimus
are estimated to have diverged only ~15,000 years before present, yet exhibit up to 10%
difference in TE abundance depending on the TE subfamily. This project will expose Mr.
Burns to cutting-edge approaches in bioinformatics, including PacBio HiFi genome
assembly, assembly quality assessment, genome alignment, TE abundance and
annotation, and pangenome analysis. This project is related to the parent proposal
because of the well-known relationship between enhancer origin and function and TE
proliferation: many TEs in vertebrate genomes are discovered to underlie enhancers with
diverse functions in multiple tissues. The parent proposal is focused on understanding
how changes in evolutionary rate of enhancers can be estimated and tied to changes in
function through high throughput enhancer assays, and this supplement will complement
Aim 2 of the parent grant by exploring possible connections between TE proliferation and
the origin of novel enhancer functions. Mr. Burns will receive in-depth mentoring focusing
on four areas critical to achieving his career goals: Finding your voice in science; the
importance of writing; acquisition of technical skills; and envisioning and planning for a
future in STEM. Together these research and mentoring activities will strengthen the
career prospects of Mr. Burns in evolutionary biology and equip him with lasting technical
and conceptual skills to allow him to achieve his career goals.

Public health relevance
Project Narrative This diversity supplement will expose the candidate to cutting-edge methods in comparative genomics, focusing on the role of transposable elements in the origin of novel enhancers. The training and mentoring will equip the candidate with career-relevant technical skills and career strategies that will equip him with lasting technical and conceptual skills to allow him to achieve his career goal of becoming faculty at an R1 university.